HPV and HIV Co-Infection: Clinical, Socio-Behavioral, and Microbiome Implications

Project Summary Abstract
There is a critical need to better understand the epidemiology and biology of oral human papillomavirus (HPV)
infection in people living with HIV (PLWH). This will, in turn, help identify the pathophysiology leading to HPV-
related manifestations such as oral and anal warts as well as oropharyngeal squamous cell carcinoma. This is
an exploratory cross-sectional prospective cohort study designed to help address this need. The goal of this
study, in line with the mission of the National Institute of Dental and Craniofacial Research (NIDCR), is to identify
markers that will help predict, prevent, and ultimately treat HPV infection and its sequelae in PLWH based on
underlying biologic, clinical, and socio-behavioral factors. Oral and anal swabs will be obtained from HPV+ and
HPV- PLWH to evaluate the microbiome in the two groups. Immune status (CD4 count and viral load) and
antiretroviral therapy (ART) regimen will be compared in the two groups and in relation to the microbiome. Clinical
findings (oral and anal lesions, diseased, missing, filled teeth) and socio-behavioral factors (sexual practices,
tobacco/alcohol exposure) will also be compared in HPV+ and HPV- PLWH. The central hypothesis is that oral
HPV co-infection with HIV will correlate with a certain degree of oral and anal microbiome dysbiosis, dysregulated
immune status and specific socio-behavioral factors. Specific Aim 1: Elucidate enrichment pathways to further
understand oral and anal microbiome dysbiosis in PLWH. Specific Aim 2: Examine immune status as well as
ART regimen in PLWH with respect to HPV infection. Specific Aim 3: Characterize the clinical and socio-
behavioral aspects that increase risk of HPV infection in PLWH. The proposed study should identify correlates
of variables that offer insight into HIV/HPV co-infection. Future research plans will include a prospective
longitudinal study to monitor for HPV persistence and the development of cancer in this cohort of PLWH.

Public health relevance
Project Narrative The proposed research seeks to better understand the correlation between biologic, immunologic, and behavioral signatures in people living with HIV (PLWH) co-infected with HPV. By seeking to understand the underlying gaps in knowledge, we will address the long standing health inequality for PLWH.